Demographic Analysis of Longitudinal Historical Data

DESCRIPTION (provided by applicant): This project will provide extremely valuable specialized training in historical demographic techniques for analyzing longitudinal data to students and researchers working in a variety of demographic sub-fields. The rational for the project is simple: Historical demography has a long history of important contributions to the theory, methods, and practice of population studies, especially in the use of longitudinal data. Historical demographers are currently making important contributions to mainstream demographic research in fertility, mortality, family systems, aging, and migration. Indeed, the size, scope, and temporal and geographic coverage of databases currently available and under construction are unprecedented. Since historical data are often longitudinal and multi-level, they raise subtle methodological problems. Meaningful analysis often requires specialized methodologies, such as family reconstitution and back projection that are unique to historical research. Since they are based on fundamental principles of demographic theory, students trained in these methods are both prepared for historical research and better able to use complex contemporary sources. Historical data can be a perfect model for analysis of demographic processes. The number of observed covariates is usually limited, and historical demographers have excelled in creatively using longitudinal and genealogical information to construct contextual and time-varying covariates. The longitudinal analysis techniques students learn will provide a roadmap for use with any data set with a time dimension, including many large contemporary data sets collected through NIH funding. This program will offer both formal courses and opportunities for practical experience with active researchers. Students will be introduced to data sets and advanced statistical techniques at the forefront of current research. We also aim to secure and archive some of the classic data sets used in earlier research and to make them available for analysis with the most modern methods.